Optimized targeted radiotherapy of pancreatic cancer

ABSTRACT
Pancreatic ductal adenocarcinoma (PDAC) has a 5-year survival rate of less than 9% and is on track to
become the 2nd leading cause of cancer deaths by 2030. This poor statistic is primarily due to the difficulty
in screening for pancreatic cancer resulting in late-stage diagnosis. Currently about 20% of pancreatic
cancers are localized at diagnosis and hence surgically removable. About 20-25% of patients have
tumors that have further progressed and require chemotherapy and radiation therapy before some of
them can have surgery. Most of the patients have metastatic disease, and the only currently available
options are conventional chemotherapies. A major challenge for developing targeted therapies to treat
PDAC has been the stroma which acts as a barrier to delivering drugs to the pancreatic cancer cells.
Hence attempts to develop targeted therapies to PDAC need to have strategies to overcome this
challenge.
Tumor associated MUC1 (tMUC1) is present on over 90% of pancreatic ductal adenocarcinoma (PDAC)
examined by immunohistochemistry, making it an extremely promising target. We have developed a
tumor specific antibody, TAB004, which specifically detects tMUC1. The TAB004 antibody has also been
fully humanized (hTAB004) to develop radionuclide imaging and targeted radiotherapy and we have
demonstrated exceptional results in a triple negative breast cancer model. However, PDAC are known
to have a desmoplastic stroma that constricts blood vessels that could deliver the radiotherapy to the
cells. Hence a full-length antibody may not be the best targeting agent for pancreatic cancers compared
to smaller molecules.
In this project we propose to conduct a structured Design of Experiments (DOE) in which we will use the
hTAB004 as well as a tandem scFv as targeting agents that will be labeled with a and b particle emitting
radioisotopes. The tandem scFv will consist of hTAB004 scFv linked with the scFv of a Human/Mouse
Serum Albumin (H/MSA) to ensure the construct does not rapidly clear via the kidneys. Such constructs
(~50 kDa) have shown faster, and deeper tumor penetration compared to full length antibodies, with
comparable uptake in the kidneys. Thus, one DOE variable (ligand size) will vary the tumor penetration
and the other variable (radioisotope) will vary the radiation range. These are the most appropriate
variables to study to develop an optimized radiopharmaceutical to target PDAC with minimal impact to
normal cells. We will test these combinations in immune competent PDAC model having the appropriate
stromal, hormonal, and immune milieu.

Public health relevance
Narrative The proposed research will develop an optimized radiopharmaceutical to target pancreatic ductal adenocarcinoma (PDAC). A systematic experimental approach will be used to study the effect of the size of the targeting agent (whole antibody versus a smaller tandem ScFv construct) and the radiation range of the radioisotope. These are factors that can play a critical role in delivering the radiation to the pancreatic cancer cells that are difficult to target because of the surrounding stromal cells and constricted blood vessels compared to other cancers. The goal is to identify the optimal immune- radiopharmaceutical configuration that will maximize the therapeutic effect while minimizing damage to healthy tissue.